IGF::OT::IGF Logistical Support for meeting titled: Imprinting of Cardiometabolic Network Memory in Obesity to be held Sept. 15-16, 2016.

Logistical support for meeting titled Imprinting of Cardiometabolic Network Memory in Obesity.